Discrimination and racial socialization on Asian American parent and youth mental health

PROJECT SUMMARY/ABSTRACT
The United States does not have sufficient science to mount an evidence-based response to combat the health
detriments of present-day anti-Asian American (AA) hate. AA parents and children are struggling with a deeply
troubling new sociopolitical context, a context with unprecedented levels of anti-Asian hate and violence fueled
by references to COVID-19 as the “China virus.” Physical assaults against AAs skyrocketed by 145% in 2020
and have spiked to 164% in the first quarter of 2021. Among AA youth, 80% report being bullied or verbally
harassed and 24% reported being shunned. Our evidence base for how racism impacts AA mental health
under “normal” circumstances is insufficient and woefully inadequate. This R01 fills a critical gap in the science
of how discrimination affects AA adolescent mental health, how adolescents respond to racial discrimination,
and the agents involved in racial socialization processes involving AA adolescents. There are no longitudinal
studies that investigate the effects of racial discrimination on AA adolescent mental health while also
incorporating novel observational methods to determine how parents, peers, and social media are racial
socializing AA adolescents. This project will follow 350 Chinese American adolescents (12-15 years), their
Chinese heritage parent, and a peer to investigate the effects of discrimination experiences, discrimination
responses, and racial socialization processes on adolescent mental health (depression, anxiety, suicidality)
and on chronic stress (hair cortisol) over three timepoints. The long-term objective is to develop a biomedical
evidence base focused on how parents, peers and social media can be leveraged to mitigate the negative
health consequences of discrimination. Our multi-method approach (observation, survey, interview, biomarker)
investigates the following aims: Aim 1. To assess how racial discrimination is associated with Chinese
American adolescent (a) mental health (depression, anxiety, suicidality) and (b) biomarkers of chronic stress
(hair cortisol) over three years. Aim 2. To determine how adolescent characteristics (internalization of the
model minority myth, ethnic identity) moderate the association between discrimination and mental
health/chronic stress. Aim 3. To (a) understand how parent characteristics (racial socialization, mental health,
ethnic identity), moderate the association between adolescent discrimination and adolescent mental
health/chronic stress (hair cortisol). We also consider “upwards socialization”; how adolescents are active
agents in their own socialization and the socialization of those around them. Discrimination during adolescence
has especially pernicious effects on concurrent and downstream adult health and understanding AA
adolescent discrimination will help identify those at risk for problematic mental health. This study will inform
urgently needed individual-, family- and peer-based interventions to address mental health for AA adolescents
who are facing unprecedented risks to mental health at this time.

Public health relevance
PROJECT NARRATIVE Asian American parents and their children are grappling with, and making sense of, unparalleled levels of anti- Asian hatred, violence and racism; experiences that are particularly harmful for Asian American adolescents who are making sense of their ethnic identity. Yet, the evidence base for the impact of racism on mental health, chronic stress levels, parent-child conversations about race, child-peer conversations about race, and social media consumption is virtually nonexistent for Asian American adolescents. The current study employs an innovative, longitudinal, mixed methods combination of surveys, parent-child and child-peer dyadic observations, and biological markers of chronic stress to investigate the health impact of the COVID-related rise in racism targeting Asian Americans; informing researchers, public health experts, educators, parents and interventions to mitigate hard to Asian American health.